Restoring Immune Tolerance in a Model of Multiple Sclerosis

Project Summary / Abstract
MS is a chronic neuro-inflammatory autoimmune disease that leads to demyelination and damage of
axons. A breakdown of immune tolerance mechanisms that permits activation of naive myelin-specific T cells is
considered an initial step in the pathogenesis. A number of pivotal studies have demonstrated that antigen Ag-
specific Tregs not only have a significant role in modulating autoimmune CNS disease, but can also be highly
effective at treating MS.2-6 Using the clinically proven adeno-associated virus (AAV) platform, we have developed
an immunotherapy that restores Ag-specific tolerance in experimental autoimmune encephalomyelitis (EAE), the
animal model of MS, that is efficient at preventing disease.1 Importantly, we demonstrate the AAV
immunotherapy is capable of suppressing both clinical disease and inflammatory response in mice with
established disease ranging from mild to severe.
In addition to primary pathogenic antigens implicated in disease initiation, neo-epitopes can emerge as
result of intra- and/or intermolecular epitope spreading during progression of EAE, and MS. The potential for
increasing multiplicity of anti-myelin autoreactivities imposes major difficulties in developing antigen-specific
therapeutic agents for MS. Not only because of the possibility that the primary target antigen and/or emerging
neo-reactivities may differ in different patients, but the that the potentially pathogenic autoreactivities to several
myelin antigens may occur in any one patient at any one time.7 Studies aimed at inhibiting the development or
progression of EAE associated with more than one pathogenic autoreactivity by antigen-specific
immunomodulation targeting have suggested that all relevant autoreactivities should be targeted for maximal
therapeutic effect.
Unlike other approaches that require ex vivo T cell engineering and/or expansion of TCR/Ag-specific T
cells, by designing the AAV vectors to express the complete protein coding sequence (not just the
immunodominant epitope) of the autoreactive protein, our approach induces Ag-specific Tregs in vivo and
eliminates the need to identify HLA/MHC specific epitopes, making this approach unique and universally
applicable.
Building on our previous results, the continuing hypothesis to be tested is that stable hepatic expression
of AAV-delivered neuroantigens will establish a robust and persistent immunological tolerance, mediated by the
in vivo induction and expansion of Ag-specific Tregs, can significantly reduce or stop disease progression in the
EAE model of MS.

Public health relevance
NARRATIVE MS is a neuro-inflammatory autoimmune disease in which T cell driven inflammation leads to demyelination and damage of axons. The overall goal for is proposal is to develop a clinically relevant Adeno-associated virus (AAV) immunotherapy that will restore tolerance in an autoimmune setting such as Multiple Sclerosis (MS). We will show that our protocol will induce and expand antigen (Ag)-specific regulatory T-cells (Tregs) in vivo and independent of MHC or epitope restrictions.